CORE--BIOSTATISTICS AND FACS

The purpose of Core Component A, the Administrative, Biostatistics, and FACS Core, led by the Program Project PI, Dr. C. Civin, is to provide all 4 projects with (1) central leadership, administrative management, and mentoring; (2) expertise and resources for biostatistical planning and analysis of laboratory and clinical experiments; and (3) expertise and resources for Fluorescence Activated Cell Sorter (FACS) analysis and cell sorting. He will directly supervise the Administrative, Biostatistics, and FACS resources of Core Component A. The Administrative resource will perform the Program Project's administrative management, including budget management, record-keeping and payments for donations of normal bone marrow, log-books and allocations of use and payments for the FACS resource and animals/animal transplant services, and generation of progress reports and related correspondence, maintenance of our weekly seminar series, leadership of working meetings of Program Project and Core Component Leaders and Investigators, and scheduling of regular meetings of our Internal and External Advisory Groups and consideration/execution of their recommendations. The Biostatistics resource will provide biostatistical support to the entire Program Project. The FACS resource will interact with Program Project investigators on all flow cytometry experiments.